Research Capacity Building Core

The LISTOS Research Capacity Building Core (RCBC) will accomplish the following
aims: (1) develop a two-tiered training and mentoring program to build implementation
research capacity for cancer control in Mexico and Latin America; (2) establish three
implementation science (IS) capacity-building units (training & resources, implementation
strategies, and methods & measurement) to coordinate and support the training and mentoring
program; and (3) create an implementation research pilot program for cancer control in Mexico
and Latin America.
In accomplishing these aims, the RCBC will address key gaps that have plagued capacity
building efforts for cancer control implementation research in LMIC settings. This core will
target gaps in capacity building through enhanced mentoring, coaching, and technical
assistance; provide novel and innovative methods of developing the capacity of investigators in
Mexico and Latin America specific to their needs; conduct trainings and develop tools in
Spanish to overcome language barriers; and establish a pilot program to expand the impact of
RCBC efforts. The three functional units of the RCBC will include investigators from all partner
institutions, fostering a collaborative environment that allows for two-way dialogue between
local practitioners and healthcare organization partners in Mexico and Latina American, and
between Mexican (INSP, INCan) and US-based IS partners (UTHealth, UCSF).
Innovative capacity building strategies will be supported through the RCBC, including
establishing Project ECHO programs in Mexico and supporting participation by local
investigators in D&I certificate programs. Key outputs of RCBC activities will include the
adaptation of and training LISTOS partners on key implementation research tools.
Implementation research tools and training will be made available to investigators in LISTOS
networks in Mexico and Latin America, as well as to members of the U54 Global Cancer
Consortium. RCBC efforts will build the capacity of a cadre of outstanding young investigators
from Mexico and Latin America to conduct cancer IS research and address cancer related health
inequities in Latin America.